PPARG regulates osteocyte bioenergetics and function during aging

Bone loss and impairment in energy metabolism with aging prevalently lead to fractures and diabetes. As an
organ, the skeleton is one of the largest consumers of energy needed for bone remodeling and maintenance of
bone homeostasis. Bone remodeling is under control of osteocytes, which constitute 90-95% of bone cells, and
which bioenergetic program is largely unknown. New evidence indicates that nuclear receptor PPARG, which
is a global regulator of energy metabolism and pharmacological target to treat hyperglycemia, regulates
osteocyte energy metabolism and their function including production of sclerostin, an inhibitor of WNT pathway
activity and a key protein regulating bone remodeling. Research proposed in this application will provide an
insight into the connection between osteocyte bioenergetics, its function in bone metabolism and systemic
energy metabolism, and whether bone acts as the body “energostat” via osteocyte endocrine activities. The
leading hypothesis is that changes in PPARG activity with aging alter osteocyte function and bioenergetics
resulting in simultaneous decrease in bone formation and decrease in energy metabolism. This hypothesis will
be tested in three specific aims. Aim 1 will determine how fuel choice and aging affect osteocyte function and
whether these processes are PPARG dependent. With the use of aged C57BL/6 and γOTKO mice, bone organ
cultures, and osteocyte-like MLO-Y4 cells with down-regulated PPARG, in combination with transcriptomics,
quantitative proteomics, and coculture experiments, PPARG contribution to osteocyte aging will be defined.
Aim 2 will contrast the PPARG protein interactome of osteocytes with the interactome of adipocytes, in
response to either full agonist rosiglitazone or the inverse agonist SR10171, in order to define an optimal
PPARG modulator for its beneficial effects on bone and metabolism. The analysis will be done on osteocyte-
like MLO-Y4 cells using quantitative Tandem Mass Tag Proteomics. Aim 3 will define dynamics of PPARG
interactome on PPRE sequences present in Sost promoter as a function of aging and in response to
pharmacological modulation of PPARG activity. The premise of this application is to set a stage for precise
pharmacologic manipulation with PPARG activities in osteocytes to simultaneously improve skeletal and
metabolic dysfunction in elderly.

Public health relevance
This proposal will investigate mechanisms by which bone is integrated with regulation of energy metabolism, and its dysregulation with aging. It will characterize a protein, which is already used as a pharmacological target to treat diabetes for its novel function in regulation of osteocyte energy utilization and activities supporting bone remodeling, and regulation of systemic energy metabolism. This knowledge is critical for the future research in which this protein will be selectively targeted in order to develop a therapy which will simultaneously improve bone quality and energy metabolism in elderly.